CORE CENTER FOR CLINICAL RESEACH IN TOTAL JOINT ARTHROPLASTY (CORE-TJA)

ABSTRACT - OVERALL
Total joint arthroplasty (TJA) is the most common and fastest growing surgery in the nation. There are
currently more than 7 million Americans living with artificial joints. Despite the high surgery volume, the
evidence base for TJA procedures, technologies and associated interventions are limited. Many surgical
approaches and implant technologies in TJA are adopted based on theoretical grounds with limited clinical
evidence. The wider TJA research community needs access to large, high quality and rich data sources and
state-of-the-art clinical research standards and information technologies to overcome methodological and
practical challenges in studies of surgical and nonsurgical interventions in TJA. The overarching goal of Mayo
Core Center for Clinical Research in Total Joint Arthroplasty (CORE-TJA) is to facilitate innovative,
methodologically rigorous and interdisciplinary clinical research that will directly improve TJA care and the
outcomes. The CORE-TJA will serve as a disease (TJA) and theme-focused Center providing shared
methodological expertise, education and data resources. The CORE-TJA will leverage big data resources for
TJA research, provide customized methodology resources in epidemiology, biostatistics, health services
research and medical informatics, and establish synergistic interactions around an integrated Core (American
Joint Replacement Registry – AJRR).
The Specific Aims of CORE-TJA are: (1) To provide administrative and scientific oversight of CORE-TJA
activities (Administrative Core), (2) To provide integrated services, access to large databases and novel
analytical methods for clinical research in TJA (Methodology Core); and (3) To meet the unique data needs of
the TJA research community and to strengthen the national capacity for large-scale observational and
interventional studies in TJA using national registry data (Resource Core). The CORE-TJA will be integrated
within the long-standing and highly centralized clinical research environment of the Mayo Clinic, thereby
leveraging existing expertise and infrastructure resources, including the Center for Clinical and Translational
Science. All CORE-TJA activities will be evaluated using robust metrics to ensure continuous evaluation,
flexibility and improvement in response to the most pressing needs of the TJA research community.

Public health relevance
NARRATIVE The Mayo Core Center for Clinical Research in Total Joint Arthroplasty (CORE-TJA) will provide methodological expertise and access to nationwide data resources to facilitate innovative, methodologically rigorous and interdisciplinary clinical research in TJA. The clinical research needs of the TJA research community that will be addressed by the CORE-TJA include training of the next generation of TJA researchers, customized consultations, facilitated access to high quality, rich data sources and national TJA registry data as well as informatics and methodology support.